A Novel Method to Enhance Drug Delivery to the Brain

PROJECT SUMMARY
Delivering molecules across the blood-brain barrier (BBB) represents a major challenge in treating mental
disorders and central nervous system (CNS) disorders. Many therapeutic agents that have the potential to treat
these disorders have difficulty entering the brain due to the presence of the BBB. In this project, we are
responding to the NIH PAR-22-031 that calls for development of delivery systems that can target drugs to the
brain. We have recently developed BBB modulators (BBBMs) that significantly increase in vivo brain delivery of
small-to-large drug molecules including therapeutic peptides and proteins. Recently, BBBMs (i.e., HAVN1 and
DWI peptides) have been shown to selectively modulate the BBB over the peripheral vasculatures in the in vitro
and in vivo systems. Our hypothesis is that these BBBMs enhance brain delivery of therapeutic proteins by
modulating cadherin-mediated cell-cell adhesion in the paracellular pathway of the BBB. The overall goal of this
project is aimed at developing and optimizing the next generation of BBBMs as a novel and non-invasive delivery
system to target drugs to the brain. BBBMs transiently increase the porosity of the BBB paracellular pathways
to allow drugs to enter the brain from the bloodstream. To accomplish the overall goal, we will pursue the
following Specific Aims. First, a combination of virtual screening and 3D in vitro models of the BBB vs. peripheral
vasculatures will be used to optimize modulatory activity and selectivity of the next generation of BBBMs from
VE-cadherin. Second, DMPK profiles, toxicity, and selectivity of BBBMs will be evaluated using animal models.
Toxicity of BBBMs in various organs will be determined. Third, the biological effects of BBBMs-facilitated brain
delivery of FL-BDNF and BDNF peptides will be evaluated in mouse models of both sporadic and familial
Alzheimer's disease (AD). The biological effects of FL-BDNF and BDNF peptides in the brain will be assessed
by determining TrkB signaling, synaptic activity, AD neuropathology, and learning and memory. If successful,
this project will have impacts on (a) reversing neurodegeneration, (b) improving diagnosis and treatment of brain
diseases and injuries, (c) expanding our understanding of how the brain works at both the cellular and molecular
levels, and (d) designing new tools for monitoring brain function in vivo.

Public health relevance
PROJECT NARRATIVE This project is aimed at developing a novel delivery method for delivering drugs to treat Central Nervous System (CNS) disorders. Using our novel blood-brain barrier modulators (BBBMs), we now can selectively deliver protein therapeutic and diagnostic agents into the brains of healthy and disease animal models without affecting other organs. Our novel delivery method can be transformed from preclinical animal studies to clinical studies in patients.